Remote Monitoring and Detecting of Tardive Dyskinesia for Improving Patient Outcomes

Abstract - Remote Monitoring and Detecting of Tardive Dyskinesia for Improving Patient Outcomes
Tardive dyskinesia (TDD) is a common debilitating side effect of antipsychotic use. Characterized most notably by
involuntary facial movements such as grimacing, involuntary lip, mouth, and tongue movements, and eye blinking,
TDD is difficult to treat and potentially irreversible. Psychiatrists and other mental health professionals are acutely
aware of the impairment and disability experienced by patients who develop TDD. Early detection of TDD is
critical so that appropriate interventions can be instituted. What interventions are implemented is intimately
tied to knowing the patient’s medication adherence. It is difficult for the most qualified diagnosticians to
devote the 20-25 minutes of in-person time at the 4 to 6 times per year frequency necessary to provide every
patient the 1) “active monitoring,” 2) discussion of results, 3) changes to medication and instructions expected
with the urgent demands on every mental health professional today. This is increasingly challenging with the
increase in telemedicine and patient populations and decreasing human resources due to the pandemic.
Unfortunately, despite professionals’ best efforts, it is often too late in the process and the involuntary movements
are permanent. Currently, there are 200,000 individuals taking anti-TDD medications costing $60K and $105K
annually and this is increasing rapidly each year. A method for automatic TDD detection and accurate adherence
would enable timely intervention and avoid patient stigma, lower quality of life, and expensive ongoing treatment
for permanent TDD.
Antipsychotic prescriptions exceeded 50 million in 2020 and the reported prevalence of TDD is between 13% and
24%. Risk grows with advancing age, off-label uses, and chronic exposure to antipsychotics. Therefore,
prevention and early detection are key to managing TDD. However, current methods for monitoring patients
require observation of patients at infrequent in-person visits or self-reporting by vigilant but undertrained patients
and their families. Therefore, strong market potential exists for an automated remote adherence monitoring and
TDD detection system. Our go-to-market strategy is presented in the commercialization plan.
This Phase II project proposes to leverage existing telepsychiatry and video interview data gathering technologies
that in Phase I demonstrated up to 77% discrimination in categorizing individuals with TDD compared to a 3-
person panel of trained clinical professionals evaluating the same video materials. Based on a power analysis of
the Phase I data, we propose here to extend collection and analysis of an additional 300 video recorded AIMS
and 5-minute video interviews with individuals taking anti-psychotic medications. Half of the interviews will be with
individuals living with diagnosed TDD and the other without a diagnosis of TDD. The participants in the study will
be recruited to ensure an equal distribution of females and males as well as an ethnically and racially
representative sample.
The proposed data gathering strategy will provide the source material necessary to finalize and deploy a powerful
supervised machine learning derived video and audio analysis tool to detect TDD. The detection tool will be
created using 80% of the collected video data as a training set and validated on the remaining 20% reserved as
the control set. Based on industry experience with other supervised machine learning training sets and the
amount of data to be collected, we set a goal of a 90% success rate in identifying TDD positive and TDD negative
participants in the control set.
Once the detection tool is complete the project will conclude by incorporating access to the tool into an existing
smartphone app, iRxReminder, that is used for data gathering and monitoring of medication adherence, the other
critical component required for clinical intervention. The iRxReminder platform links patients directly to
researchers and their electronic records. The modified app will be tested in the laboratory to ensure the interface
can be easily used. This Phase II project will then use the iRxReminder platform for use in supporting the self-
management and TDD and other symptoms monitoring of medication taking by individuals living with chronic
mental illnesses. With feasibility established in Phase I, we propose a six-month long clinical trial where
participants will 1) be monitored for early detection of TDD (and confirmation of not having TDD, thus avoiding
unnecessary diagnostician time) along with 2) goals for high adherence, 3) improved control of symptoms and
side effects, and 4) more aggressive and frequent treatment responses by the healthcare team. Statistical tests of
the ease-of-use by patients and the care team will be conducted. The impact on revenue, treatment trajectory
(number of side effects detected and medication changes made) will be assessed. The success of the algorithm
to detect TDD compared to a human assessment at the end of 6-months of monitoring will be a final field test of
the technology.

Public health relevance
A key study reported that TDD rates among newly treated elderly ranged from 7.2% for those taking Risperidone to 11.1% for those taking olanzapine after 2 years of treatment. Earlier meta-analyses estimate TDD frequency in women to be 26.6% and in men 21.6%. Ethnically Chinese and Malaysian mental health patients were studied in Singapore and patients taking anti-psychotic medications were found to have TDD in 40% and 29% of cases respectively. Regardless of prevalence, TDD is a threat to patient adherence and quality of life. TDD only remits in a minority of cases and can be permanent. With 50 million prescriptions for anti-psychotics written annually, more than 44 million persons living with a chronic mental illness are at risk of developing TDD. There are likely over 1.65 million patients living with TDD and the number of patients with TDD is expected to grow with the aging population and increasing off-label use of antipsychotics. This trend is likely accelerated with the increased isolation of existing patients and the increased need for psychiatric treatment due to the pandemic.